Neural and cognitive consequences of COVID-19 survival.

The SARS-CoV-2 pandemic has been going on for over a year worldwide, with 115,000,000
confirmed cases and over 2,500,000 deaths (as of Mar 3, 2021). We are seeing people recover
from the initial COVID19 infection with complaints of ongoing problems. An increasing number of
people are complaining of cognitive deficits and depression/anxiety. Veterans are at a higher risk
of COVID19 infection as well as suffering complications due to a number of co-morbidities.
Veterans with neurocognitive complications may experience premature aging and
neurodegeneration that could manifest as a huge burden for health care.
We have brought together two laboratories studying neurocognitive impairment using an EEG,
MRI, and behavioral approach as well as laboratory-based data. The Ford lab proposes to query
neuropsychological function in Veterans using a computerized internet-based neuropsychological
battery, EEG-based measures, functional MRI (connectivity) and structural MRI (gray and white
matter volumes, myelin, micro-bleeds). The Pulliam lab has preliminary data to show a continued
increase in plasma cytokines in COVID19 survivors. Plasma isolated neuronal enriched
extracellular vesicles (nEVs) showed an increase in amyloid beta, neurofilament light and pT181-
Tau, all proteins associated with neurodegeneration. The Overall Aim is to determine the extent
of the cognitive, clinical, and neurological damage in people recovered from COVID19.
The Specific Aims are to: 1) characterize neuropsychological function in COVID19 survivors, 2)
assess EEG and MRI data in COVID19 survivors, 3) determine whether peripheral inflammation
and markers of neuroinflammation, aging, and neurodegeneration persist in nEVs, and 4) explore
relationships between neurodegenerative and inflammatory blood markers and EEG/MRI/NP
measures while considering pre-existing co-morbidities and complications of COVID19.

Public health relevance
The novel coronavirus SARS-CoV-2 infection, (COVID), continues to rage throughout the world with 115,000,000 confirmed cases and over 2,500,000 deaths (as of Mar 3, 2021). This translates to millions of people surviving COVID19 infection. While the lungs are ground zero, COVID19 tears through organ systems from brain to blood vessels. We are now beginning to see people recover but complain of ongoing problems, including lingering cognitive problems, depression, and anxiety. We have brought together 2 laboratories with complementary techniques including psychological testing and neuroimaging methods together with markers in the blood that may signal damage in the brain. A close look at these problems is timely and imperative if we are to understand the pathophysiology of “COVID brain” and prepare for downstream problems.